ISES 2023 Annual Meeting

Abstract
The International Society of Exposure Science (ISES) is the premier
international society devoted to bringing the full value of exposure science
to research and decision-making to improve human health and the
environment. This conference represents the most prominent and
comprehensive gathering of environmental exposure scientists and
environmental health professionals from academia, government, and
organizations from around the world, reflecting the interdisciplinary nature of the field.
The theme of the 33rd ISES Annual Meeting is “Connecting Communities and Science through
Addressing Environmental Exposures.” The conference will specifically focus on new and
emerging challenges for humans and the ecosystem. These challenges include extreme
weather, natural disasters, wide application of pesticide, chemicals in consumer products, air
pollution in both developed and developing countries, and multiple environmental stressors
people are exposed, etc. Environmental exposures may affect human health and the ecosystem
in a complex and non-linear way. Exposure and health issues also vary between local, regional,
and global scales. Understanding the complex nature of environmental exposures, the health
impacts, and relevant strategies and policies to improve environmental health requires the
knowledge, analytical methods, and data collection tools developed from multiple disciplines and
applied at different scales.
Meeting topics include application of sensors in exposure assessment, citizen science and
community-engaged research, climate change impacts on human exposure, COVID-19,
vulnerabilities in environmental exposure and health, new and emerging environmental
exposures, exposure data to policy action and impacts of public health policy, multiple
exposures and interactions, risk communication, statistical methods in exposure science and
epidemiology, and technology/sensors. There will be an added focus on environmental justice
and community engaged research as it relates to the field of exposure science.
The 33rd ISES annual conference will be held in Chicago, IL from August 27-31, 2023 and will
continue the success of previous meetings. The meeting offers four and half days of cross-
disciplinary presentations and discussions of new research and methods of international,
national, and regional significance and facilitates the exchange of information and ideas among
exposure science and environmental health scientists from academia, government agencies,
non-profit organizations, and industry. Conference attendance is between 500 to 700
participants principally from North America and Europe. ISES has encouraged attendance of
students and new researchers, as well as of investigators from low- and middle-income
countries over the last 5 years resulting in an average of 15% increase in the number of
attendees. This proposal will support the representation of students and new researchers from
underrepresented backgrounds as well as provide an opportunity for participation of community
members, hence enhancing member diversity, promoting the global development of exposure
science, and fostering collaborations and information exchange both nationally and
internationally.

Public health relevance
Narrative The International Society of Exposure Science (ISES) is the premier international society devoted to bringing the full value of exposure science to research and decision-making to improve human health and the environment. This conference represents the most prominent and comprehensive gathering of environmental exposure scientists and environmental health professionals from academia, government, and organizations from around the world, reflecting the interdisciplinary nature of the field.